Targeted Identification of IBD Risk Gene Variant Impact on Immune-Epithelial Crosstalk and Intestinal Barrier Function

Project Summary
Single nucleotide polymorphisms (SNPs) in the protein tyrosine phosphatase N2 (PTPN2) gene are
confirmed risk markers in both forms of inflammatory bowel disease (IBD), Crohn’s disease (CD) and
ulcerative colitis (UC). PTPN2 loss-of-function variants reduce PTPN2 activity and are associated with
more severe disease in IBD patients. While we and others have utilized PTPN2 knockdown and
knockout models to generate preliminary insights into the potential contributions of PTPN2 loss-of-
function in IBD development, there is very little information as to how PTPN2 clinical variants
compromise intestinal homeostasis. A major contributor to this knowledge gap lies in the lack of suitable
model systems to study PTPN2 variants in intestinal epithelial cells, the critical cell type that comprises
the gut barrier. To address this, we propose to utilize IBDGC resources to 1) identify gene clustering,
expression, and biological pathways altered in IBD patients carrying the PTPN2 rs1893217 loss-of-
function variant; 2) generate novel in vitro models that will allow us to mechanistically probe key targets,
perform challenge and rescue (using pharmacologic and genetic approaches) experiments; and 3)
generate novel gut-on-chip models to integrate these findings into a more physiologically relevant
experimental system.
Outcomes & Impact: This proposal will capitalize on our expertise in studying roles of PTPN2 in
multiple facets of IBD pathophysiology by utilizing the unique resources of IBDGC to develop cutting-
edge models for a greater translational understanding of how PTPN2 variants contribute to IBD. These
models will also represent a significant advance to the field for discovery biology and for future
‘personalized’ drug development studies.

Public health relevance
Project Narrative: Single nucleotide polymorphisms (SNPs) in the protein tyrosine phosphatase N2 (PTPN2) gene are confirmed risk markers in inflammatory bowel disease (IBD), and are associated with earlier onset and increased severity of disease. There are a lack of suitable model systems to study how PTPN2 variants compromise the function of intestinal epithelial cells, the critical cell type that comprises the gut barrier. In this proposal, we will utilize the unique resources of the IBDGC to develop cutting-edge models to uncover a greater translational understanding of how PTPN2 variants contribute to gut barrier dysfunction in IBD, and create novel tools for future ‘personalized’ drug development studies.